Knowledge Base and Portal

Summary (Knowledgebase and Portal Core)
The Knowledgebase and Portal Core (KPC) of the Indiana University-Ohio State University Maternal and
Pediatric Precision in Therapeutics Data, Model, Knowledge, and Research Coordination Center (IU-OSU
MPRINT DMKRCC) will develop a knowledgebase and web portal of data and resources relating to maternal
and pediatric therapeutics. The KPC will collaborate with Pharmacometrics and Clinical Trial Design Core, Real-
World Evidence Core, and other collaborators to support common data elements and ontology development,
knowledgebase construction, and web portal development. The Aims of the KPC will be 1) to develop common
data elements and ontology for annotating pharmacology data in children and pregnant/lactating women,
including those with disabilities; (2) Develop text classification algorithms to identify published literature in
pediatric and pregnant/lactating women; (3) Integrate various data sources relating to pharmacokinetics,
pharmacodynamics, pharmacogenetics, pediatric ontogeny and the physiological changes that occur with and
around pregnancy and lactation that influence drug metabolism, distribution, and drug response;
pharmacogenomics, pharmacometrics modeling; and drug toxicity and efficacy in maternal and pediatric
populations; (4) Develop a data portal for knowledge data sharing and dissemination. The KPC will work with
the MPRINT Hub Steering Committee to set research priorities and milestones and with the Outreach,
Dissemination and Training Core to disseminate results and provide education on pharmacometric approaches
applied to maternal and pediatric therapeutic research.